Wnt-Retinoic Acid Regulation of Gastric Epithelial Cells

PROJECT SUMMARY
This new R01 application proposes to define a novel signaling axis regulating gastric epithelial cell
homeostasis and response to injury. The gastric mucosa is organized into gastric glands lined with a columnar
epithelium that is renewed by gastric stem cells throughout lifespan. Wnt is an essential niche pathway
regulating stem cell function, with activation associated with hyperproliferative gastric disease. Wnt signaling
regulates two important cellular functions in the glandular stomach: stem/progenitor cell proliferation and chief
cell differentiation. Although these roles have been established, questions remain about how Wnt promotes
these gastric epithelial cell functions. Interestingly, chief cells, differentiated cells that secrete digestive
enzymes, also operate as reserve stem cells in the gastric glands, remodeling after injury into proliferating
metaplastic cells to repair the epithelium. How Wnt signaling regulates this regenerative process is not known.
Our extensive preliminary findings identified retinoic acid signaling as a potential novel Wnt effector pathway in
the gastric epithelium, regulating both gastric stem cell function and chief cell identity. This project tests the
hypothesis that Wnt activates retinoic acid signaling to maintain gastric epithelial cell homeostasis and to
regulate chief cell remodeling after injury. To address this hypothesis, we will independently manipulate Wnt
and retinoid acid signaling in the gastric epithelium in mouse in vivo models and in vitro organoid models, and
gastric stem cell and chief cell (reserve stem cell) function will be measured. High dose tamoxifen treatment
will be used to induce gastric injury to activate chief cell remodeling in mouse. Histological analysis and lineage
tracing will measure gastric epithelial cell proliferation and differentiation during homeostasis and after injury.
Because both Wnt and retinoic acid signaling are transcriptional pathways, our studies include bulk and single
cell RNAseq analysis to identify cellular changes, and gene and pathway targets. In addition to using genetic
and pharmacologic approaches to manipulate Wnt and retinoic acid signaling, mice will be fed Vitamin A
deficient diet to deplete body retinol stores to uncover retinoic acid function in the stomach. Gastric organoid
studies will define epithelial specific responses to Wnt and retinoic acid signaling. Notably, both mouse and
human gastric organoids will be analyzed, including previously characterized high-Wnt organoids established
from Familial Adenomatous Polyposis patient gastric polyps. Together the proposed studies will establish a
Wnt-retinoic acid signaling axis in the stomach regulating epithelial cell function. The information learned from
this project will provide functional insights to develop a deeper understanding of Wnt and retinoic acid pathway
regulation of gastric stem cells (active and reserve). Furthermore, defining mechanisms of Wnt-retinoic acid
regulation of gastric stem cell function is important to refine strategies to propagate adult stem cells in culture
for regenerative therapies as well as to develop potential therapies for gastric hyperproliferative diseases.

Public health relevance
PROJECT NARRATIVE This project will define basic mechanisms of stomach tissue maintenance and uncover molecular pathways that are important for cellular repair after tissue injury. The findings will advance knowledge of gastric stem cell biology, which is important to refine strategies to propagate adult stem cells in culture for regenerative therapies and to develop potential therapies for gastric hyperproliferative diseases.